Center for Cellular Metabolism Research in Oklahoma

PROJECT SUMMARY/ABSTRACT
Altered cellular metabolism contributes to the pathogenesis of many common diseases that are prevalent in
Oklahoma. This Center for Cellular Metabolism Research in Oklahoma (CMRO) Phase I COBRE aims to
create and nurture excellence in cellular metabolism in Oklahoma.
Two of the current CMRO COBRE Research Project Leaders (RPLs) (Drs. Lee and Cleuren) and two of our
graduating RPLs (Drs. Yu and Zhao) use confocal microscopy for their research programs. Additionally, five
CMRO COBRE mentors (Drs. Xia, Griffin, Olson, Srinivasan, and Kovats) routinely use confocal microscope
for their research. A Nikon C2+ confocal microscope that was purchased in 2017 to support eight investigators
at the Cardiovascular Biology Research Program of OMRF is currently used by thirteen investigators, nine of
whom are associated with COBRE (69.2%). The RPLs and their mentors are the heaviest users of the C2+
confocal and have relied on this equipment to produce top-notch images for their research at no cost.
However, the C2+ confocal is starting to show evidence of aging and overuse in the form of increasing
numbers of service calls and down time. Furthermore, the newer confocal microscopes have many technical
capabilities that are not available in the C2+ confocal. For example, the Nikon AXR microscope is capable of
scanning 2X larger area of the sample at 16X higher resolution and 2X higher sensitivity to the signal. The
AXR can also acquire images at a much faster speed, which is ideal for larger samples and live imaging.
Additionally, the AXR is capable of deconvoluting the acquired images and improving the resolution even
further. This supplement requests partial support for a new Nikon AXR confocal microscope. OMRF will
provide 50% of the total cost for the equipment. The requested equipment will reduce the demand on the C2+
confocal, supporting our COBRE RPLs in building their competitive research programs and transitioning to
independence.

Public health relevance
PROJECT NARRATIVE Confocal microscopes are essential for the success of the Research Project Leaders and their mentors of the Cellular Metabolism Research in Oklahoma COBRE. This administrative supplement requests partial funds for purchasing a Nikon AXR confocal microscope. This new microscope will substantially improve the competitiveness of the COBRE by increasing our technical capability and reduce the burden on an aging and failing confocal microscope.